Delineating the role of cell cycle control of acquisition and maintenance of the invasive phenotype

Abstract/Project Summary: The cell cycle is critical for health and disease. Defects in the cell cycle result in disruptions in morphogenetic behaviors as well as cancer. In order to understand how the cell cycle impinges on morphogenetic and disease processes, I am developing a fluorescence cell cycle state biosensor for use in C. elegans. This cell cycle state biosensor is dynamically localized between the nucleus and cytoplasm over the course of the cell cyle via cyclin dependent kinase activity. Ratiometric measurement of the cytoplasm and nucleus allows for direct quantification of cell cycle state. Additionally, I am developing a software package for automated image analysis of ratiometric data for use in C. elegans. As a test case, I will characterize the cell cycle in the morphogenesis of the C. elegans vulva and uterus. One of the cells in the uterus, the anchor cell, invades through two layers of basement membrane to contact the underlying vulval epithelium, forming the connection between the uterus and the vulva required for ovoposition and initiating vulval morphogenesis. The anchor cell can only invade the basement membrane in G1/G0—a cell cycle state that may be broadly associated with the ability to breach the basement membrane in both cancer metastasis and development. This cell cycle arrest is mediated by both cell cycle components and chromatin modifiers. Using the cell cycle indicator developed by this proposal, I will identify the genetic mechanism by which the G1/G0 pro- invasive cell cycle arrest of the anchor cell is maintained.

Public health relevance
Narrative: During development, cell cycle arrest is required for differentiation and often to facilitate morphogenesis. Cell cycle arrest is also required for acquisition of cell invasive behavior, critical for trophoblast implantation, mammalian gastrulation, neural crest migration, cardiac development, and immune surveillance. Inappropriate invasive activity is also the key step in tumor spread or metastasis. Insights gained by mechanistically determining how cell cycle regulation mediates cell invasive activity will aid in the treatment of diseases associated with invasive behavior, including pre-eclampsia, rheumatoid arthritis, asthma and cancer.